Exosomes and the Immune Response in Allograft Outcomes in Pediatric Transplant Recipients

PROJECT SUMMARY/ABSTRACT
Solid organ transplantation is currently the treatment of choice for children with a variety of end-stage
organ diseases. The success of clinical transplantation is dependent on the use of potent
immunosuppressive drugs to prevent rejection of the allograft. However, even with our arsenal of
immunosuppressive agents, between 10-40% of pediatric transplant recipients will have a rejection
episode in the first-year post-transplant. Clearly, acute rejection remains a major hurdle in pediatric solid
organ transplantation and thus is the critical question to be addressed in the proposed mechanistic study.
The CTOT-C “Biomarkers for Post-Transplant Lymphoproliferative Disorders in Children” will enroll over
1000 pediatric recipients of liver, heart, kidney or intestinal grafts and thousands of individual blood
samples will be collected, processed (whole blood, PBMC and plasma) and stored at Stanford. In this
proposal, the unique CTOTC-06 cohort of samples, clinical data and established infrastructure will be
utilized to identify novel and robust surrogate endpoints of allograft status. In preliminary studies we have
identified microRNAs and cellular phenotypes that correlate with either acute rejection or stable graft
function. We now propose to determine the exosome miRNome, analyze TCR and immunoglobulin heavy
chain repertoires, and perform a multi-parameter analysis of the alloimmune response by mass cytometry
with the goal of identifying biomarkers of stable graft function and acute rejection in recipients of liver,
heart, kidney and intestine transplants. We hypothesize that we can identify unique cellular, molecular,
and functional changes in the immune response that are associated with and predictive of graft outcomes.
We will test this hypothesis in the following specific aims:
Aim 1: Determine the impact of an allograft on the early post-transplant immune response.
Aim 2: Establish novel diagnostic and predictive approaches to determine allograft status.
The development of novel and robust surrogate endpoints of allograft status will be a major advance in
the field of pediatric solid organ transplantation.

Public health relevance
Project Narrative Solid organ transplantation is an important therapeutic option for children with a variety of end stage diseases. However, graft rejection remains a significant challenge and we are hampered by our inability to determine which children are at highest risk of developing rejection. In this proposal, we will leverage the unique CTOTC-06 cohort of samples, clinical data and established infrastructure to develop novel immune-mediated markers that are associated with and predictive of graft outcomes.